Modeling West Syndrome to Prevent Neurobehavioral Disabilities

West syndrome is the most common of the catastrophic epilepsies of early childhood. Onset is most often
within the first year of life and babies with this disorder have very brief seizures (only a few seconds in
duration) – thus the coining of the alternate name infantile spasms. The epileptic spasms commonly occur in
clusters of up to 100 in a few minutes. The spasms, along with the highly chaotic EEG patterns called
hypsarrhythmia, are thought to contribute to the severe intellectual disabilities seen in most children. Indeed
neurodevelopmental arrest or regression is frequently observed upon spasm onset. Other neurobehavioral
comorbidities evolve as well including hyperactivity. In terms of treatments, ACTH and vigabatrin are FDA
approved to stop the spasms and are effective in ~ 50% of children. However, both drugs can produce serious
side effects. More importantly, while these drugs can eliminate spasms in some children, most often the
neurobehavioral comorbidities persist and are life-long. Thus treatments are needed that will not only stop the
spasms but also prevent the intellectual disabilities and other neurobehavioral deficits. Recent large
multicenter clinical trials have reported more optimistic outcomes. They suggest that prompt diagnosis and
rapid elimination of spasms can result in improved neurobehavioral outcomes. For instance, outcomes are
better if treatment is initiated within 1 week of diagnosis rather than 2 months. These results and others like
them have led to a position statement endorsed by the Child Neurology Society and American Epilepsy Society
that prompt treatment of epileptic spasms is essential in order to prevent worse developmental and intellectual
outcomes. In this application, we propose to establish the TTX animal model of infantile spasms for the
discovery of new treatments to prevent neurobehavioral comorbidities. The model already has good external
validity. In addition, preliminary results reported here indicate that animals with spasms have learning and
memory deficits and an accompanying hyperactivity phenotype. We propose 4 specific aims. In the first, we
will fully characterize the learning and memory deficits and hyperactivity phenotype in these animals. In the
second, we will establish the best dosing for a novel combination therapy of vigabatrin and the neuroactive
peptide (1-3)IGF-1 that synergies with vigabatrin to enhance GABAergic synaptic transmission and rapidly
eliminates spasms in a large majority of animals. In the third and fourth aims, we will establish the predictive
validity of the model by treating rats with the combination therapy and showing that early elimination of spasms
and hypsarrhythmia will ameliorate neurobehavioral comorbidities but delayed treatment will not. If successful,
these studies will establish the TTX model as a much-needed tool for discovering less toxic and more effective
new therapies, which will significantly improve long-term outcomes for children with this devastating seizure
disorder.

Public health relevance
Project Narrative. Infantile spasms is a severe childhood seizure disorder. Most children become intellectually impaired after the onset of these seizures. Our goal in the experiments proposed is to demonstrate the TTX animal model has very similar neurobehavioral deficits as children and show that early treatment with drugs that abolish spasms can prevent or at least ameliorate these behavioral deficits.